GAMMA GLOBULIN AND AZT IN CHILDREN WITH HIV INFECTION

The objective of this study is to evaluate the clinical, immunologic and virologic effects of AZT plus placebo as compared with AZT plus IVIG in children with symptomatic HIV infection.